DC Partnership for HIV/AIDS Progress (DC PFAP)

In its first 11 years, the program has successfully partnered with Alan Greenberg of the George Washington University School of Public Health and Health Policy and formed a network of the 15 largest HIV providers in the District of Columbia

The project has created a common data base for the 15 providers, linking key HIV related information for patients being seen at all sites who agree to participate in the observational cohort that has been created. The DC Cohort is overseen by the DC PFAP Steering Committee but managed by Alan Greenberg, Amanda Castel, and Anne Munroe of GW School of Public Health. The Cohort now has more than 11,000 HIV positive volunteers among DC's 17000 persons with HIV. This is the largest urban HIV cohort in the nation. An increasing number of high quality publications are being produced. The cohort received 5 years of NIH funding in 2020, and Dr. Castel received her first cohort related R01 grant related to a cohort study on tobacco cessation.

The DC PFAP Subspecialty Clinics were established as a distinct pillar of DC PFAP in order to address the increasing prevalence of medical co-morbidities that are affecting the health of people living with HIV/AIDS (PLWHA), targeting underinsured and disenfranchised populations. Medical co-morbidities have become a major concern among the PLWHA community as people are living longer with HIV infection as a direct result of improved antiretroviral medications. Unfortunately, morbidity and mortality rates have now become a result of problems such as liver disease, renal disease, cardiovascular disease, metabolic disorders and malignancies, which may be related to HIV, to concurrent infections, or to non-infectious co-morbidities.

Since June 1, 2009, the Subspecialty Clinics have been created and the providers have started to engage patients in the medical care of hepatitis C viral infections. It is crucial to the DC PFAP mission that these programs become integral components of the health care community in DC, and embed their services within the existing community HIV and Primary care medical clinics. Over 1600 patients with HCV have been evaluated for studies at community-based sites. This program is the leading clinical research program in the US focusing on the development of new HCV therapeutics and the delivery of such drugs. DC PFAP leaders appear at many national meetings, and were founding leaders and members of the AASLD-IDSA national guidance on HCV Management, the gold standard for management in the US.

The Program has also focused on the role of marginalized patients in propagating the epidemic. Clinical sites in northeast and southeast DC have been designed to assess the characteristics and molecular viral sequences of HIV and HCV in these populations, and compare them to new case isolates to determine which subgroups are most important regarding new cases of HIV and HCV. The GRAVITY study has enrolled 500 marginalized persons to determine their incidence and prevalence of HIV and HCV. Molecular epidemiologic analysis is underway to determine their link to new cases in DC.

Given the importance of opioid use disorder in contributing to risky behavior that promotes HIV and HCV transmission, and given the importance of opioid sue disorder in interfering with adherence to PREP and ART, DC PFAP has been funded by NIH OD to also deal with new strategies for combatting substance use disoder since this is such an impediment to HIV prevention and therapy.
In 2019 a phase I study of ANS 6697 was completed at the CC to meet FDA requirements for drug development for a novel compound that reduces cravings. This study has been suspended due to hepatotoxicity of the lead compound and will resume if the sponsor can develop a molecule that targets the same dopamine pathway and does not have unacceptable toxicity

Currently the project continues to focus on marginalized populations that are either not in care or not in effective care. These populations appear to be central to the continued persistent incidence of HIV in Washington DC. The clinical operation has expanded focus on opioid use disorder and has completed a needs assessment with George Washingoton University Medical Center, University of Maryland, Emory and University of West Virginia to determine what deficiencies are there in services for hospitalized patients with OUD related infectious complications in terms of both inpatient services and linkage to reliable outpatient services.

The CHOICE study has been funded by HEAL and NIDA to address how inpatients can more reliably access therapies for substance use disorder, being started on such therapy, and be linked to durable care. This study started enrolling at 4 sites in 2025.

In 2024-25 the project has received OAR Innovation Awards to assess the use of long acting amphetamines to reduce the impact of methamphetamine abuse on HIV care, and the use of GLP agonists to reduce the impact of cocaine.ALARM for amphetamine use disorder should start enrolling patients in third quarter 2025, and the semaglutide study should start enrolling in the fourth quarter.